Immunity in the Nose to inFLUENza: Correlates of Efficacy (INFLUENCE)

The upper respiratory tract is the site of initial infection with respiratory viruses, such as influenza.
T cells and antibodies at this mucosal site form local immune memory and are positioned to
provide sterilizing immunity. Despite this known importance in preventing infections, mucosal
immunity is understudied relative to its peripheral blood counterpart. This has resulted in a weak
understanding of the contribution of mucosal immunity to preventing viral infection, and those
factors that could be enhanced in next-generation influenza vaccines. This proposal aims to
address two major technological limitations that have hindered our understanding of mucosal
immunity. Firstly, studies have suffered from a lack of well validated and consistently applied tools
for sampling the respiratory mucosa. Nasosorption is a minimally invasive, well tolerated,
sampling tool that yields highly reproducible data on the abundance of protein mediators in the
human nose. Here, nasosorption will be employed to collect respiratory secretions from healthy
control volunteers and analyzed alongside biobanked samples arising from human infection
challenge studies of influenza. This first aim seeks to demonstrate the utility of nasosorption as a
human nasal sampling tool that can bring a greater level of consistency to future immunology and
vaccine efficacy studies. Secondly, studies have suffered from an inability to determine the
functional activity of mucosal antibodies. This inability has arisen from the focus of research on
systemic immunity, where antibody titres are higher than in mucosal secretions. Existing
technologies such as haemagglutination inhibition, neutralization, and antibody-mediated
cytotoxicity assays are therefore either insufficiently sensitive or not optimized for use with
mucosal samples. To address this technology gap, this proposal aims to develop the use of
pseudovirus neutralization and FcγR-dimer binding assays to study the activity of mucosal
antibodies against influenza. These technologies are ideally suited to mucosal samples as they
have greater sensitivity than classical approaches and can be readily modified to study new
antigens as viruses evolve and vaccines emerge. Utilizing samples from human infection
challenge studies with wild-type (H1N1) influenza and vaccine-virus (LAIV) samples enables the
testing of these technologies in a tightly controlled setting and analysis of the homo- and hetero-
subtypic immune responses resulting from infection/vaccination. Finally, the robustness of the
developed technologies will be tested to enable widespread dissemination of the techniques,
enabling the understanding of mucosal immunity in future studies of influenza vaccines.

Public health relevance
Next-generation influenza vaccines need to induce long-lived heterosubtypic immunity, particularly in the upper respiratory site of initial infection. Existing technologies are insufficient for profiling mucosal humoral immunity at the functional level required for testing future vaccines. To resolve this limitation, this proposal aims to partner highly standardised sampling of the upper airway by nasosorption with flexible, scalable, sensitive assays for neutralisation and Fc- dependent antibody function.